Biostatistics & Bioinformatics Shared Resource

PROJECT SUMMARY: BIOSTATISTICS AND BIOINFORMATICS SHARED RESOURCE
The Sylvester Comprehensive Cancer Center (Sylvester) Biostatistics and Bioinformatics Shared Resource
(BBSR) provides investigators ready access to critical services and expertise not usually available in individual
laboratories, including state-of-the-art biostatistics and bioinformatics services to support clinical trials and
laboratory and population-based cancer research studies. The BBSR supports hypothesis generation, study
design, data analysis, and interpretation, and provides training in quantitative science applications. The aims of
the BBSR are to 1) conduct rigorous, reproducible, and transparent statistical and bioinformatics data analysis
and interpretation; 2) provide expert scientific review, data monitoring, and statistical oversight of clinical and
population science research protocols; 3) deploy and develop new analytical techniques; and 4) provide
training on analysis and application of data from existing and emerging technologies. The BBSR provides 1)
statistical and bioinformatics services for study design, power analysis, sample size estimation, and feasibility
assessment for basic, translational, and clinical research; 2) statistical and genomic data analysis services; 3)
statistical review of clinical and population science research protocols; and 4) consultation and training. The
scope, complexity, and usage of services provided by the BBSR have steadily advanced. For the current
reporting period (6/1/2018-5/31/2023), a total of 172 principal investigators (PIs) utilized BBSR services,
including 97 Sylvester members from all Research Programs (RPs), who comprised 88% of usage as
measured by revenue, reflecting the critical importance of BBSR services to Sylvester members. The BBSR
supported 161 publications by members, of which 25% (40 publications) were in high-impact journals (JIF
≥10), and it facilitated 54 cancer-related extramural grants awarded to members, including 22 NCI awards. In
addition, the BBSR supported 63 cancer-related investigator-initiated studies (40 by members) and provided
770 statistical reviews for Sylvester regulatory committees. The BBSR also offered seminars, lectures,
workshops, and training sessions. In 2023, Sylvester recruited Yan Guo, PhD, as Director BBSR. His extensive
experience and expertise facilitate the BBSR growth needed to support the evolving needs of Sylvester
members, in alignment with Sylvester’s 2024-2028 Strategic Plan. To meet the growing needs of Sylvester
members, the BBSR expanded from six personnel at the end of FY22 (May 2022) to 12 personnel at the end of
FY23 (May 2023). Future plans are to 1) enhance BBSR support for design of precision medicine approaches
and for characterization of cancer heterogeneity (e.g., by using artificial intelligence (AI) and deep learning); 2)
expand analysis services for existing and emerging high throughput technologies (e.g., long-read sequencing
and spatial multiomics); and 3) broaden use of high-performance computing clusters and cloud-based
resources to meet the increasing demand for analyzing large scale datasets to advance cancer research.